Development of a novel biodegradable inorganic nanoparticle therapeutic for cancer

Abstract
Bladder cancer is the sixth most prevalent cancer malignancy. More than 80,000 new cases are diagnosed
in the USA each year, among which 75% are non-muscle-invasive bladder cancer (NMIBC). High-risk NMIBC is
often treated with intravesical instillation of Bacille Calmette-Guérin (BCG), a bacterial vaccine, following
surgically removing major tumors. While generally considered well tolerated, local and systemic side effects are
common with BCG and can lead to discontinuation of the therapy in up to 20% patients. Moreover, about 30%
patients do not respond to BCG. These patients require radical cystectomy with urinary diversion or
chemotherapy and radiation, both of which are associated with considerable morbidity. Furthermore, BCG is
currently in great shortage due to limited production and an increasing global demand. There is an urgent need
of new treatment options that afford high efficacy, can be manufactured easily, and are better tolerated by
patients.
Our objective is to develop a safe and effective intravesical therapy based on phospholipid coated sodium
chloride nanoparticles (SCNPs). These nanoparticles can enter cells through endocytosis and degrade inside
them to release large amounts of Na+ and Cl-. This entails an increase of intracellular osmolarity, which causes
plasma membrane and mitochondrial membrane depolarization, leading to cell necrosis and apoptosis. It is
hypothesized that SCNPs as an intravesical therapy can be applied to affected bladder to kill bladder cancer
cells. After therapy, SCNPs are reduced to NaCl salt, which is safely excreted via urine or absorbed by the host.
Meanwhile, because SCNPs induce immunogenic cell death, it is also expected that intravesical SCNPs can
stimulate an anticancer immunity that helps prevent tumor recurrence and progression. In this project, we will
test these hypotheses first in vitro and then in vivo with murine orthotopic tumor models. Affording unique cancer
cell killing mechanisms and minimal side effects, SCNPs hold great potential in clinical translation as a novel
treatment option for bladder cancer.

Public health relevance
Project Narrative This project aims at developing and testing sodium chloride nanoparticles as a novel intravesical therapy for non-muscle-invasive bladder cancer. It is hypothesized that sodium chloride nanoparticles can be instilled into affected bladder for efficient cancer cell killing. After the treatment, sodium chloride nanoparticles are degraded to non-toxic salts and excreted via urine or absorbed by the host, causing minimal local and systemic toxicity.